VisionWay: Accessibility-aware Path Selection for Wayfinding

Project Summary
A major challenge faced by People with Visual Impairment (PVI) is wayfinding outside. Existing solutions,
such as TappyGuide, leverage a user’s smartphone to generate directions to a destination. However, a barrier is
that the followed path may not be accessible because sidewalk features such as potholes, uncontrolled crossing,
interrupted sidewalks, and objects are not known in advance. Our goal is to develop a mobile live, local,
outside map framework called the VisionWay, customized for PVI-user as a wayfinding tool to analyze,
before starting to walk, the accessibility of candidate paths and choose one to the destination.
To address this challenge, barrier, and achieve our goal, we assembled a team of men, women, trainees, and
members who have lived experience with vision impairment (VI). Our strengths include engineering, computer
science, human factor engineering, mixed methods research, implementation science, clinicians including low
vision and orientation and mobility specialists (OMS), as well as team members and participants with VI. We
designed aims for R61 technology development and feasibility, and R33 prototype expansion. Specifically, in R61,
Aim 1: we will study how to measure and detect PVI Accessibility on Sidewalks. R61, Aim 2 we will examine
PVI-centered modality for adoption of multimodal path presentation, path scores, and descriptions across various
navigation scenario complexities. In R33, Aim 3 we will generalize, integrate, and test the VisionWay framework.
Finally, in R33, Aim 4 we will plan for implementation with dissemination and maximize sustainability of this
PVI-centered accessible wayfinding map.
Upon the successful completion of these aims, our goal is to deliver the VisionWay framework that include
multimodal vibro-audio feedback, and live updates of dynamic data that inform about accessibility of pedestrian
paths. The expected outcomes include dissemination and sustainability plans for the long-term growth of the
proposed VisionWay map deliverable.

Public health relevance
Project Narrative A major challenge faced by People with Visual Impairment (PVI) is wayfinding outside. While existing so- lutions, such as TappyGuide, leverage a user’s smartphone to generate directions to a destination, a barrier is that the followed path may not be accessible because sidewalk features such as potholes, uncontrolled crossing, interrupted sidewalks, and objects are not known in advance. The goal of this project is to develop a mobile live, local, outside map framework called the VisionWay, customized for PVI-user as a wayfinding tool to analyze, before starting to walk, the accessibility of candidate paths and choose one to the destination.